Optimization of protective antibodies response against bacterial adhesins

ABSTRACT
The primary goal of this proposal is to understand how conformational properties of the major pathogenesis
factor of E. coli - most common, type 1 fimbrial adhesin of E. coli - defines its ability to elicit a protective
antibody response as a vaccine candidate against urinary tract infections caused by E. coli. FimH is an
adhesive subunit of the type 1 fimbriae and is one of the major factors in the ability of E. coli to bing human
urothelium and cause urinary tract infection. We determined that the mannose-binding lectin domain of FimH
can assume two conformational states - with a high- and low-affinity towards terminally-exposed mannosyl
residues. The conformational shift in FimH is highly dynamic in nature and is the basis of the ability of FimH to
mediate shear-enhanced bacterial adhesion, bind fast and strongly human cell receptors and shed bound
antibodies. We intend to perform a comprehensive functional analysis of antibodies against both
conformational states of FimH to analyze the conformational switch in FimH in the context of the immune
response against the adhesive protein.

Public health relevance
NARRATIVE The primary goal of this proposal is to understand how the ability of most common Escherichia coli adhesin, FimH, to dynamically change its structure is affecting the type of antibodies that are produced against it. We intend to perform a comprehensive analysis of the molecular and protective properties of the antibodies in context of the their specificity and inhibition of the bacterial cell adhesion and ability to cause UTI.